Animal Models and In Vivo Imaging Core

Project Summary – Animal Models and In Vivo Imaging Core
The Animal Models and In Vivo Imaging Core will meet the needs of participating investigators for using animal
models of ocular diseases to conduct basic and translational vision research. The Core will provide access to
advanced technologies and highly qualified technical support for generating and performing in vivo ocular
imaging of animal models. The availability of animal models coupled with comprehensive in vivo tissue
structure and function assessment will greatly accelerate study of molecular and cellular mechanisms
underlying ocular disease processes, and facilitate translation of basic science findings for diagnostic and
therapeutic applications. The specific aims are to provide instrumentation and technical expertise for: 1)
generating and maintaining animal models of ocular diseases, performing surgical procedures, obtaining
samples for genotyping, and harvesting ocular tissues; 2) enabling investigators to use various in vivo ocular
imaging and tissue function testing technologies; 3) training investigators and research staff on the utility and
operation of ocular imaging and function testing equipment; and 4) consultation regarding the appropriate
animal models, surgical and imaging procedures to address research needs of participating investigators.
.